Structure and mechanism of the mitochondrial ATP synthase and Batten Disease gene product, Cln3p

Research Strategy Abstract An estimated 20-30% of all open reading frames in the eukaryotic cell encode a membrane protein and an estimated 60% of all drugs bind to a membrane protein. Not surprisingly, statistical analysis of the current drugs indicate that hydrophobicity is one of 8 properties that is common in a drug target. However, the number of high-resolution structures of membrane proteins is relatively small and the number of structures of hydrophobic molecules bound to membrane proteins is even smaller. This proposal has 2 disparate projects whose only commonality is that the proteins under investigation are membrane proteins and involved in critical functions in the cell. The first project entails the yeast mitochondrial ATP synthase of which we have solved the first near atomic model of the entire monomeric enzyme and we did this, with and without inhibitors bound to the membrane embedded, Fo domain. We propose to expand these studies to provide structures of the ATP synthase inhibited or trapped in various reaction intermediates. Our approach is unique in that we have linked 2 subunits of the ATP synthase and this allows us to capture intermediates with the rotor in a twisted state. As such, our approach allows for the capture of reaction intermediates. The use of inhibitors will serve to trap intermediates and identify their mode of binding. The second project is studies on yeast Yhc3p, a homologue of human Cln3p, which is in humans, is defective in the juvenile neurodegenerative disease, Batten. While, Cln3 was reported in 1995 as the gene defective for the juvenile form of Batten disease, the function of this protein is still unknown. Based on homology and other data, we hypothesize that Cln3p is a small molecule transporter whose function is tied to the formation of oxygen radicals. We have evidence that the yeast gene, YHC3, is tightly regulated and believe that by identifying the regulation, we will understand its importance in the cell. Lastly, we have developed an over-expression system and purification scheme for Yhc3p, which we will use to study the function and start crystallization trials for x-ray diffraction studies. While disparate, these projects fall well within our expertise and will add to the base necessary for the understanding of membrane proteins in health, disease, and as targets for drug discovery.

Public health relevance
Project Narrative i. Justification for requested instrument. I am requesting an ultracentrifuge with a high capacity rotor and bottles. This will be a dedicated centrifuge for the project. The centrifuge will increase the productivity of the laboratory, ensure the availability of the centrifuge, and it will ensure a reliable instrument. First, I will discuss productivity. This will be a dedicated instrument for the project. A single current ultracentrifuge is currently being shared with the other laboratories (2-3) in the Center. At present, the Hasting's laboratory is the primary laboratory with potential conflicts and while that lab is funded by the NIH, it is not by NIGMS. We are in the process of hiring an Assistant Professor with a target start date for Fall, 2021. A dedicated ultracentrifuge will ensure that we have complete access to an ultracentrifuge as needed and prevent delays and conflicts. Second, we have concentrated much of our effort from isolation of enzyme from yeast mitochondria to membranes isolated from yeast from a 150,000 x g fractionation. We are working extensively on an integral membrane protein (about 50 kDa) that resides in the membrane of the yeast vacuole – or lysosome – from the Batten project. However, because we are doing structural work approaching it in parallel by cryo-EM and crystallography, we need a large amount of pure protein. At present, we can work with about 400 ml of total cell extract, which is just about 1/5 of the amount of material we have. Working with 2 rotors and 2 centrifuges, we can double our capacity. Third, the ultracentrifuge will also allow us to run 2 different preparations simultaneously. This need occurs when we are to either express 2 different variants of the goals on the Batten project or when also working on the Specific Aims for the ATP synthase project. Fourth, there is a matter of a safety net. The shared current single ultracentrifuge is 18 years old and needs frequent services. Last year, my laboratory moved to new research space and I was separated from the shared instrumentation that I had access to prior to the move. Thus, currently, I only have designated access to 1 centrifuge that is dedicated to 2-3 laboratories. While there is possible access to another single ultracentrifuge on the same floor, it is dedicated to other laboratories. Thus, there is concern that experiments can be unexpectedly delayed. A delay by a single day can have a big effect on the progress as the experiments are designed for the week, with each day having a necessary goal for the entire week. While I wish I could say that there are other investigators on the floor that have funding from NIGMS, I cannot. The NIH funding for the other laboratories is from different institutes. ii. Why Instrument was not anticipated when the original application was submitted. When this application was first submitted and approved, my laboratory was in a different building and I had access to many more centrifuges. There has been a reorganization of the research into “Centers”. I am in the Center for Genetic Diseases based upon my studies on Batten and mitochondrial diseases. The remaining members of the Biochemistry Department were moved into a different center, which is on a different floor. Before the reorganization, I had access to multiple centrifuges which provided sufficient access and backup. In the move, the Center for Genetic Diseases was provided only a single ultracentrifuge which has changed the dynamics of the environment. This division was not anticipated when the grant was first submitted and was not even determined until last year just before the move. iii. Routine training and maintenance. All users need to get permission for use, they must sign-up, and all users are trained by myself in the presence of the post-doctoral fellow. The university will pay for the maintenance agreement, which we have a quote for $3422/yr. iv. Timeline for installation and use. We will order and install as soon as we get notification of the award. We will start using it as soon as it is installed. Budget Justification My project budget never included money for a ultracentrifuge as I did not foresee a need. My major current costs revolve around personnel and cost for cryo-EM. The personnel costs increase with each year and the carryover from the current year is already committed to the existing personnel. The university has committed $5,000 to the cost of the centrifuge in addition to the annual maintenance contract. The budget projection to the end of the current fiscal year is about a 24% surplus based on the total costs but just 20% of the total direct costs. However, the budget will be much tighter in the coming year as we are making significant progress and moving to higher costs. I anticipate that there will be no surplus at the end of the coming year.